Liposomal azithromycin to treat cardiac inflammation

Coronary artery disease is the leading cause of morbidity and mortality in the US leading to over 1 million
myocardial infarctions (MI) annually. The inflammatory response associated with MI leads to an influx of
circulating immune cells, particularly neutrophils, monocytes, and macrophages, into the myocardium. This
response is crucial for removing dead tissue and initiating the healing process. However, exacerbated
inflammation following MI and other cardiomyopathies can be detrimental and is associated with infarct
expansion, poor cardiac remodeling, and adverse clinical outcomes. Modulating inflammation represents a
paradigm shift in the treatment of MI, but clinical translation has not been realized. Therapeutic transition of
macrophages to a reparative phenotype represents a promising strategy to reduce the damage responsible for
heart failure after MI. To address this, we have prepared a liposomal formulation containing azithromycin (AZM),
a clinically approved antibiotic, that has been shown to modulate immune responses to favor repair. The overall
goal of this project is to advance the preclinical development of liposomal AZM (L-AZM) for clinical translation.
The rationale for this proposed research is based on the need to identify treatments with improved therapeutic
index to minimize the inflammation and fibrosis associated with adverse cardiomyopathies including MI.
Encouraged by strong preliminary data, our goals are based on clear milestones that address current gaps in
knowledge to further de-risk the technology and position it for clinical translation. The R61 phase will be
completed through the following specific aims: 1) Determine the optimal dose initiation and formulation
parameters that enhance the therapeutic index of AZM, and 2) Determine the optimal duration and dose of our
lead L-AZM formulation to reduce myocardial inflammation. The R33 phase will be completed through the
following specific aims: 1) Determine the efficacy of the optimal L-AZM regimen in murine and porcine models
of cardiac inflammation, and 2) Determine the pharmacokinetic parameters in murine and porcine animal models.
Completion of both milestone-driven phases of the award will result in the data necessary to advance the
technology toward IND-enabling studies for eventual clinical translation. The milestones of this proposal are
well-defined to advance pre-clinical development of L-AZM focused on identifying a treatment regimen that
results in a survival benefit in animals. The approach is innovative and addresses an unmet need due to: 1)
the repurposing of AZM in liposomes to polarize phagocytes toward a reparative phenotype to preserve cardiac
muscle post-MI, and 2) our approach to assess formulations in an in vivo model with the goal of improving the
therapeutic index of AZM. There are currently no therapies approved to treat the post-MI inflammatory response.
This research is significant as the proposed aims are low risk, yet high impact and focus on improving our
understanding of AZM in a liposomal formulation to reduce the pathological inflammation in patients post-Ml.
Project Summary/Abstract

Public health relevance
PROJECT NARRATIVE This proposal seeks to continue preclinical development of a liposomal formulation containing azithromycin as a therapeutic strategy to modulate the inflammatory immune response associated with myocardial infarction. The objectives of this proposal will improve our understanding of the dosing regimen, targeting of immune cells, safety, and efficacy of our current lead formulation to continue pre-clinical development. These data will serve as the basis for future clinical translation to reduce the burden of cardiac inflammation in patients.